RNA regulation of inflammatory mediators in glial cells: a novel therapeutic target for neuropathic pain after nerve injury

Neuropathic pain (NP) is a devastating consequence of peripheral nerve injury that most often affects
younger people. NP is often chronic and resistant to current treatments leaving the patient with persistent
disability. A key factor in the genesis of NP after nerve injury stems from activation of microglia in the spinal
cord at the level of injury. This activation leads to the production of pro-inflammatory cytokines that
hyperexcite neurons transmitting pain. Pro-inflammatory chemokines also draw in peripheral immune cells
including macrophages and T cells which amplify and sustain the inflammatory milieu underlying NP. A
common regulatory thread for pro-inflammatory mediators, including IL-1β, IL-6, TNF-α, iNOS, CXCL1, and
CCL2, is at the mRNA level where adenine- and uridine--rich elements (ARE) in the 3’ untranslated region
(UTR) modulate mRNA stability, translational efficiency, and ultimately protein expression. Our prior work
has identified HuR as a major positive regulator of these mRNAs in glial cells by binding to the ARE,
translocating to the cytoplasm, and augmenting translation. Our team has developed a novel class of small
molecule inhibitors that block HuR dimerization, a process necessary for its nucleocytoplasmic translocation
and positive regulatory effect. We have shown that the prototype, SRI-42127, potently suppresses
microglial activation and the production of pro-inflammatory cytokines and chemokines. In a recently-
published pilot study with the spared nerve injury (SNI) model of NP, we observed a significant attenuation
of allodynic pain in male and female mice after administration of SRI-42127 (8). Using a microglial-selective
HuR knockout mouse model developed in our laboratory, we found that the allodynia-mitigating effect could
be recapitulated only in male mice, indicating a sex dimorphism. In this proposal we hypothesize that
HuR drives NP after nerve injury through its positive regulation of pro-inflammatory cytokines and
chemokines by resident microglia for male mice and macrophages for female mice. Furthermore,
inhibiting HuR function chemically or by genetic deletion will attenuate this response and reduce
NP. We propose 3 specific aims: (1) Investigate the required dosing schedule, longevity and applicability of
HuR inhibition by SRI-42127 following SNI in male and female mice, (2) Assess the cellular and molecular
mechanisms whereby SRI-42127 attenuates NP after SNI in male and female mice, and (3) Explore sex
differences in immune cell-specific HuR inhibition following SNI using conditional knockout mouse models for
microglia and macrophages. The long term objectives of this proposal are: (1) to advance our small
molecule HuR inhibitors as a potential therapy for NP, and (2) to gain an understanding of how ARE-
mediated RNA regulation impacts NP and the sex-dependent cell types that drive it. The innovation of this
proposal is the investigation of a novel class of HuR inhibitors for targeting the acute inflammatory response
in NP and the mechanistic investigation of post-transcriptional pathways in NP. The significance of this
application extends beyond peripheral nerve injury as the same HuR-regulated pathways drive
neuroinflammation in other forms of NP.

Public health relevance
Neuropathic pain after nerve trauma is a devastating event that affects younger Veterans, often on the battlefield, and is associated with long-term disability and the potential for opioid addiction. Within minutes after nerve injury, there is a robust inflammatory response characterized by the release of pro-inflammatory mediators from specialized cells in the spinal cord and the periphery. These mediators initiate neuropathic pain through the hyperexcitation of pain-propagating nerve cells which then ultimately leads to chronic pain. This proposal will investigate SRI-42127, a novel drug that inhibits HuR, a key protein which drives the production of inflammatory mediators linked to neuropathic pain. This molecule can be given peripherally (e.g. on the battlefield) and it quickly suppresses the induction of these pain-producing inflammatory mediators and mitigates the genesis of NP. This research proposal is therefore directly relevant to Veteran health and has the potential to improve quality of life for those who suffer from injury-induced neuropathic pain.